Identifying novel regenerative treatments for CNS injury in adult mammals

Abstract
We propose to study whether targeting both the transcription factor ZNF362 and cytoskeletal non-muscle
myosin IIA and IIB (NMIIA&B) will promote better axon regeneration and functional recovery after spinal cord
injury (SCI) than either approach alone. After SCI, severed axons fail to regenerate largely because of the
reduced intrinsic growth capacity of adult CNS neurons and the poor environment for axon extension. Treatments
to recover paralysis and other lost functions are not available and patients with SCI are often permanently
disabled. Many genes have been determined to control the regrowth failure of mature neurons, but none have
been translated to clinical use. There is a persistent need to identify better gene targets and therapeutic
strategies. ZNF362 is highly expressed in the CNS, but its major function in mammals remains largely unknown.
The PI’s group generated ZNF362 conditional knockout (cKO) mice and designed novel small peptides to block
ZNF362 function selectively. Our pilot studies suggest that ZNF362 strongly suppresses the growth capacity of
CNS neurons in adult rodents. After CNS injury, various inhibitory molecules around the lesion activate neuronal
RhoA, which, in turn, activates cytoskeletal NMIIA&B to condense actin filaments and restricts microtubule
protrusion and axon elongation. Because neuronal cytoskeleton is the major machinery to drive axon growth and
the converging targets of multiple signaling pathways that control axon growth, manipulating neuronal
cytoskeleton is also very attractive to promote significant CNS axon regeneration. We hypothesize that inhibiting
both ZNF362 and NMIIA&B represents a dual approach for enhancing neuronal growth capacity and reducing
environmental inhibition around the lesion. We propose to dissect potential critical roles of ZNF362 and NMIIA&B
for controlling regrowth of mature CNS neurons and to develop novel and effective strategies for promoting CNS
axon regeneration. We aim to stimulate robust axon regrowth and functional recovery in SCI rodents by
suppressing these genes using cKO mice and new selective antagonist peptides designed in our lab. In Aim 1,
we will study whether transgenically deleting ZNF362 and NMIIA&B acts synergistically to promote axon
regeneration and recovery in adult mice with SCI. Aim 2 proposes to determine whether blocking individual
ZNF362 and NMIIA&B signals pharmacologically with novel selective antagonists promotes axon regeneration
and recovery in adult rodents with SCI. In Aim 3, we plan to develop combination therapies that block both
ZNF362 and NMIIA&B signals, aiming to yield robust axon regrowth and functional recovery in adult rodents with
SCI. Based on the promising results of our pilot studies, we anticipate that our novel regenerative strategies will
significantly advance our ability to treat SCI. If our peptides are successful with rodent SCI models, we plan to
move this work to peptide safety assessments and further translational studies (e.g., cervical/chronic SCI and
clinical trials). Therefore, this project may facilitate identifying novel molecular targets for CNS repair and
highly effective strategies for treating CNS lesions.

Public health relevance
Narrative We propose to study the potential crucial roles of transcriptional factor ZNF362 and cytoskeletal non- muscle myosin IIA & IIB genes in suppressing axon regeneration after spinal cord injury and to develop highly effective systemic therapies for CNS injury in adult mammals.